Decoding dynamic interplay between signaling and membranes in chemotaxis by molecular actuators

Chemotaxis occurs during a number of key physiological events including angiogenesis, embryonic
development and wound healing. It also contributes to disease progression in pathological conditions such as
cancer metastasis and arthritis. The goal of the current proposal is to reveal how biochemical reactions and
physical characteristics, such as membrane curvature, deformation, and assembly phase, interact with one
another in achieving dynamic, accurate yet highly efficient cell migration. Chemotaxis has been understood
mainly in the perspective of signal transduction, while if and how physical properties of membranes play a role,
and how they interact with signal transduction remain largely unknown. By newly developing and implementing
a series of molecular actuators that can directly probe membrane properties with high spatio-temporal precision
inside lively migrating cells, we will reveal an interplay between signal transduction and membrane mechanics.
What molecular mechanisms generate local membrane curvatures developing into filopodia and
lamellipodia? In sensing chemoattractants, cells polarize by undergoing asymmetric membrane deformation
consisting of filopodia and lamellipodia at the front, and membrane retraction at the rear. We recently found that
curvature-sensitive proteins are a missing link between actin cytoskeleton and membranes. The result made us
hypothesize that actin machinery and curvature sensing and remodeling proteins, when properly modulated in a
feedback loop, are sufficient to produce desired types of membrane deformations such as lamellipodia and
filopodia. We will thus identify a particular combination of Rho GTPases, actin regulators, and BAR proteins, and
the molecular logic thereof, that are responsible for formation of filopodia and lamellipodia.
How do signaling components in migrating cells respond to membrane deformation? Migrating cells
exhibit dynamic morphological changes at plasma membranes and nuclear envelopes “as a consequence” of
cytoskeletal rearrangement regulated by signal components. To explore a possibility that membrane deformation
talks back to cytoskeletal and signal components, we will deploy molecular actuators that can directly deform
membranes. We will then quantify subsequently emerging activity of signaling components such as receptor
tyrosine kinases, PI3K, and small GTPases, as well as transcription factors such as YAP and Elk.
How does the phase-separated cytoskeletal biomolecular condensate play a role in membrane
deformation? Actin networks can undergo formation of biomolecular condensates at the plasma membrane due
to weak multivalent interactions among actin regulators. To examine the physiological importance of such phase
separation events, we will adapt molecular techniques to assemble or disassemble the condensates. These
operations will uniquely achieve gain- or loss-of function manipulations without altering an amount of the
molecular constituents; what is altered is their physical assembly status. We will characterize cell migration
phenotypes before and after deploying phase manipulations.

Public health relevance
Relevance to Public Health Due to its significant involvement in biological processes, chemotaxis contributes to disease progression in cancer and arthritis, while its impairment leads to anomalous tissue development or regeneration. Our unique molecular actuators that can exert “physical force” specifically onto intended intracellular objects, can be a tool for not only dissecting the molecular mechanisms of chemotaxis, but also interfering with these cell migration-related diseases.